Hemodynamic Adaptation and Vascular Remodeling in Fistula Development

PROJECT SUMMARY AND ABSTRACT
The vascular access is the lifeline for the hemodialysis patient. The most common etiology of vascular access
dysfunction in hemodialysis patients is failure of an arteriovenous fistula (AVF) to mature successfully for
dialysis use (AVF maturation failure). At present, there remains a very high rate of AVF maturation failure in the
United States and there are no effective treatments to enhance AVF maturation. On a radiologic level, AVF
maturation failure is most commonly characterized by a stenosis at the venous anastomosis, and at a
histological level it is characterized by a combination of aggressive neointimal hyperplasia and poor outward
remodeling. The poor outcomes following AVF creation reflect our limited understanding of the mechanisms
leading to AVF maturation failure; and the lack of therapies to treat this clinical problem represent an unmet
clinical need. The objective of this proposal is to understand the role of the endothelial nitric oxide synthase
(NOS3)/nitric oxide (NO) system in AVF development. Preliminary work from our rodent AVF models has
demonstrated: (1) impaired endothelial-dependent vasorelaxation (decreased NOS3-derived NO
bioavailability) at the AVF anastomosis, (2) poor hemodynamic adaptation and biological responses in the
setting of NOS3 dysfunction, (3) increased AVF neointimal hyperplasia and matrix metalloproteinase
production in the setting of chronic kidney disease, and (4) reduced neointimal hyperplasia and improved
vascular biological responses to a NO-releasing bionanomatrix gel applied directly at the AVF anastomosis
during AVF creation. Based on these preliminary studies, the central hypothesis of this proposal is that the
NOS3/NO system plays a critical role in successful AVF maturation by regulating local vascular hemodynamic
adaptation and vascular biological responses after AVF creation; and locally delivered NO therapies applied at
the AVF anastomosis can improve these two processes. Using our murine and rat AVF models, we will test our
central hypothesis with two specific aims: (1) To determine how the NOS3 system modulates hemodynamic
adaptation and biological responses during AVF maturation and (2) To evaluate the effect of a nitric oxide-
releasing nanomatrix gel administered locally at the AVF anastomosis during AVF creation on enhancing AVF
development. We believe our proposed research is significant because: (1) it addresses a very important
clinical problem in hemodialysis patients, AVF maturation failure, where there are presently no effective
therapies and (2) examines a fundamentally important system in AVF development, the NOS3/NO system.
Successful completion of these aims will identify important targets for developing innovative therapies that aim
to modify the NOS3/NO system in order to enhance AVF maturation. Our results will also have broad
implications for other vascular conditions such as peripheral arterial disease, coronary artery disease, and
postangioplasty restenosis.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because of the majority of arteriovenous fistulas created in hemodialysis patients in the United States fail to mature for successful use on hemodialysis with many fistulas requiring interventions to promote maturation. Improving the understanding of the pathobiology of arteriovenous fistula maturation failure will lead to development and testing of novel therapies to treat this important clinical problem. Thus, the proposed research is relevant to the part of the NIH’s mission that pertains to developing fundamental knowledge to help reduce morbidity and mortality for patients on hemodialysis by improving arteriovenous fistula development.